SIGIRR in the Neonatal Intestine

ABSTRACT
Developmentally regulated programs that inhibit pathological activation of intestinal Toll like receptors (TLR) by
gut microbiota are deficient in preterm infants. A life-threatening consequence of intestinal dysmaturity in preterm
infants is a loss in barrier function to gut microbiota resulting in necrotizing enterocolitis (NEC), characterized by
inflammation, bacterial invasion, and necrosis. A lack of insight into the immunogenetic mechanisms regulating
intestinal barrier function and TLR sensitivity during postnatal gut adaptation has limited our knowledge of NEC.
Our laboratory has a long-standing interest in studying how genetic mutations program deviant host-pathogen
interactions underlying NEC. We have reported that Single Immunoglobulin Interleukin-1 Related Receptor
(SIGIRR) inhibits TLR-mediated intestinal inflammation by inhibiting NFκB and inducing STAT3 signaling in
neonatal mice. SIGIRR variants identified in human NEC exaggerate inflammation in intestinal epithelial cells
(IEC) exposed to bacterial ligands, while SigirrMut mice encoding a SIGIRR mutation (p.Y168X) identified in NEC
exhibit TLR hypersensitivity and impaired intestinal adaptation. Ongoing studies reveal that SIGIRR deficiency
leads to a marked loss in the IEC adherens junction (AJ) and tight junction (TJ) proteins, E-cadherin and zona
occludens 1, which programs increased gut permeability to pathogenic Gram-negative bacteria (GNB). Seeking
mechanistic insight into the loss of E cadherin in SigirrMut mice, we investigated TWIST1, a bHLH family
transcription factor that transcriptionally represses E-cadherin enabling cellular metastasis in cancer. IEC
TWIST1 expression and nuclear translocation were induced in SigirrMut mice and in intestinal autopsy samples
obtained from preterm infants with NEC. These pilot data inform our central hypothesis that SIGIRR promotes
AJ assembly and IEC barrier function in the neonatal intestine by inhibiting TWIST1-mediated repression
of E-cadherin. In sequential aims, we will the test this hypothesis by studying whether IEC-SIGIRR: 1) regulates
AJ assembly and function in the neonatal gut, 2) inhibits TWIST1-mediated repression of IEC AJ and TJ function,
and 3) prevents experimental NEC in mice by inhibiting TLR4 and TWIST1 signaling. SIGIRR regulation of IEC
AJ and TJ component members, TWIST1 inhibition, and gut permeability to GNB will be evaluated in transgenic
mice with global or IEC-specific loss/gain of SIGIRR function. Surgical pathology NEC samples and preterm
infant enteroids transduced with SIGIRR variants identified in NEC will provide human corroboration to SIGIRR’s
role in preserving AJ function through TWIST1 inhibition. We will also examine the opposing effects of SIGIRR
and TWIST1 in regulating NEC vulnerability in Sigirr transgenic mice and preterm intestinal enteroids.
We study SIGIRR as a paradigm to reveal how host genetics regulates intestinal barrier function during
postnatal adaptation. This proposal impacts the field by discovering SIGIRR-TWIST1’s role in regulating IEC-AJ
assembly and function using innovative strategies. The significance lies in revealing novel mechanisms by which
genetic variants program the defective mucosal barrier in NEC with the potential for clinical translation.

Public health relevance
Defects in the intestinal mucosal barrier function contribute to the pathogenesis of necrotizing enterocolitis (NEC), a devastating disease associated with significant morbidity and mortality in preterm infants. The mechanisms by which genetic defects in intestinal immune responses to gut microbiota contribute to impaired neonatal barrier function and NEC vulnerability remain poorly defined. In this proposal we will study how genetic mutations in single immunoglobulin interleukin-1 related receptor identified in human NEC program intestinal invasion of pathogenic bacteria and NEC vulnerability using transgenic mice and human enteroid models.